HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS)

The HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS) includes an
Administrative Core to facilitate the Center goal of realizing technology modules that are then integrated into an
open-source, open-architecture system. The Admin Core will oversee the operations of the Center, coordinating
the progress and interconnections between the 5 NEST Projects so that the Technology Integration and
Dissemination (TID) Core is able to finalize the system and share it broadly with end users.
This is primarily accomplished by the efforts of the investigators and dedicated Center staff to provide
strategic leadership, project management support, and as a liaison to external partners, including NIH program
managers. By consolidating administrative responsibilities and connecting them directly through shared staff
with the TID Core, the individual NEST Projects can focus on their technical goals and timelines. The staff team
will also facilitate intra- and inter-Center meetings as well as reporting to the External Advisory Committee and
NIH. The structure allows all investigators to participate in the decision-making process and strategy while staff
are able to manage day-to-day operational needs.

Public health relevance
Not applicable per solicitation. Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRAsystems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.